CACHET - Pilot Project

1. PILOT PROJECT PROGRAM: ABSTRACT
The ChicAgo Center for Health and EnvironmenT (CACHET) Pilot Project Program is designed to fund new
directions in environmental health sciences (EHS) research and provide a primary mechanism for developing
the careers of CACHET members. The Pilot Project Program is critical to promoting the success of CACHET
investigators and the development of future CACHET resources in EHS research. Indeed, in the current
abbreviated funding cycle, this program funded 28 pilot awards totaling $639,000 in research dollars to
Center members. To date, these awards have directly led to five NIH-funded R01 and one K08 grants
totaling $11,329,383, while five submitted grants are pending and four were submitted but not funded. Pilot
projects awarded through this program explore new EHS research areas, build research collaborations and
teams (within each institution, between the two institutions and externally), support the next generation of
EHS researchers and accelerate external grant support of CACHET members. Proposals that consider data
collected by the Community Engagement Core (CEC) as well as proposals that actively collaborate with CEC
community participants are encouraged. This focus enables CACHET to respond directly to community
identified environmental research needs and, in so doing, undertake research aimed at examining how
adverse environmental factors contribute to heterogenous patterns in health outcomes across population
groups. Innovative and high-risk/high-reward studies are also encouraged. The Pilot Project Program has
four primary award types: Young Investigator Award, Idea Award, Focused Research Award and Inter-
Institutional Award; each addresses specific needs for building and supporting a strong EHS research
community in Chicago. Proposals are reviewed for scientific merit, feasibility, community- relevance, and
potential to lead to external grants in EHS research from NIEHS and other funding agencies. Funds awarded
by the program are not only essential for cultivating the careers of junior investigators by enhancing their
success in obtaining grants and publications, but also for attracting established investigators from other
disciplines into the EHS research field and fostering new collaborations. We are confident that in the next
five years, the Pilot Project Program will result in a substantial increase in NIEHS funding for CACHET
investigators, will noticeably expand EHS research capacity in Chicago, fostering the next generation of EHS
researchers and will contribute to environmental health efforts in the Chicago area.